Integrative Computational Models for Decoding Disease Mechanisms and Predicting Drug Synergies in Spatial Transcriptomics

PROJECT SUMMARY/ABSTRACT
Cellular Spatial Organization (CSO)—the spatial arrangement of cells within tissues—plays a critical role in
shaping the tissue microenvironment, disease progression and therapeutic outcomes, particularly in complex
conditions such as cancer, neurodegenerative diseases, and inflammatory disorders. Recent advancements
in Spatially Resolved Transcriptomics (SRT) offer unprecedented capabilities to map gene expression at or near
single-cell resolution while preserving spatial context. However, the high costs and technical complexities
associated with SRT limit its application in large-scale, phenotype-rich studies. This challenge necessitates the
integration of SRT data with accessible clinical datasets, such as bulk RNA-seq from large patient cohorts, to
reveal critical insights into how CSOs drive disease mechanisms. Current computational methods, however,
primarily focus on unsupervised analysis of spatial patterns in SRT data, limiting our ability to link CSO patterns
with essential clinical outcomes such as patient survival, therapeutic resistance, and drug combination
responses. My research program will address this gap by developing scalable statistical and computational
methods that integrate SRT data with clinical outcomes, enabling us to uncover how CSO influences disease
progression and treatment efficacy. Over the next five years, my lab will: (1) Develop a matrix factorization-based
model to integrate SRT data with bulk RNA-seq and clinical phenotypes to identify CSOs that are associated
with key outcomes, including survival and therapeutic response, and provide insights into how spatial cellular
architecture contributes to disease progression. (2) Design a deep learning framework that combines SRT with
pharmacogenomic data and drug chemical features to predict how spatial heterogeneity affects drug responses,
with the goal of identifying synergistic effects in complex microenvironments. (3) Develop a spatially informed
polygenic regression model that integrates Genome-Wide Association Study (GWAS) data with SRT to identify
disease-associated CSOs, revealing how genetic variants influence spatial cellular organization and highlighting
novel therapeutic targets. To ensure robustness and clinical relevance, we will collaborate with leading
biomedical research laboratories at Brown University, applying our computational methods to answer key
biological questions, such as understanding cancer progression and drug responses. By bridging spatial
genomics and clinical data, our work will address critical gaps in linking CSO to disease outcomes, enhancing
precision medicine and advancing therapeutic strategies.

Public health relevance
PROJECT NARRATIVE This project will develop novel statistical and computational methods to integrate Spatially Resolved Transcriptomics (SRT) data with clinical, pharmacogenomic, and GWAS data to uncover how Cellular Spatial Organization (CSO) influences critical clinical phenotypes, such as patient survival and drug synergy, in complex tissues. By modeling drug efficacy and resistance within the context of CSO and identifying disease-associated CSOs, this research will shed light on how drug combinations interact with spatially distinct cell populations. These tools will address current limitations by integrating diverse data sources, advancing our understanding of how spatial heterogeneity drives disease progression and shapes therapeutic responses.